TESTOSTERONE REPLACEMENT--PROTEIN METABOLISM AND LEAN BODY MASS IN HYPOGONAD MEN

The role of androgen in body protein economy and to provide mechanistic correlates to the clinical course of hypogonadal patients undergoing testosterone treatment.